Temporal Coding and Palatability in Gustatory Cortex

Project Summary/Abstract
We like to think of taste as working relatively simply—a sweet taste is recognized as sweet by virtue of
activating certain cells on the tongue, and that information is used to drive neurons that cause us to eat
more of whatever food is in our mouths. The truth, however, is much more interesting: a taste hits the
tongue, and complex circuits in the brain go into action, passing food-related information back and forth as
the system as a whole decides whether the morsel is palatable enough to swallow. My lab studies this
process by recording from multiple parts of the taste system while active rats are sampling various tastes.
We have observed this decision-making process in action in taste cortex, where neural ensembles report,
in turn, that a taste is on the tongue, that the taste is (say) sugar, and that it (the rat) currently likes the
taste; this last step appears to be one arrived at suddenly, in a moment of insight—the food rolls around in
the rat’s mouth for 0.5-1.5 seconds, and then the decision is made. This process clearly involves and
requires cortex, but it is just as clear that cortex doesn’t work alone. Here, we will do rigorous tests of
where that information in cortex comes from (specifically examining the roles played by amygdala and
hypothalamus), in the process revealing novel systems-level mechanisms of taste processing. As a whole,
this research project has the potential to completely change the way we think about taste, and to usher in
new thinking about perception in general—thinking that makes a great deal more biological sense, given
the complexity of brain circuitry.

Public health relevance
Project Narrative When a taste is placed on our tongues, we must recognize that a taste is on the tongue, identify that taste, decide whether it’s palatable or not, and then either swallow it or expel it. This thought process can be observed to play out in the firing of neurons in taste cortex, but evidence suggests that cortex doesn’t work alone. We will rigorously test how the amygdala (the seat of emotion in the brain) and hypothalamus (the center that controls hunger and thirst) work with cortex, and with one another, to make taste decisions happen, and how these decisions get implemented by motor circuits—adding to a systemic understanding of taste that will help us fight against a spectrum of feeding-related disorders.